Mechanisms of parvovirus replication in viral hepatitis

Project Summary
The study of animal viruses has been critical for understanding basic disease mechanisms, including the
pathogenesis of related human viruses. This Mentored Clinical Scientist Research Career Development Award
proposal presents a five-year research program to study the mechanisms by which a novel parvovirus
successfully replicates in terminally differentiated hepatocytes. Equine parvovirus-Hepatitis (EqPV-H), a novel
Copiparvovirus, is known to cause hepatitis and fulminant hepatic necrosis in horses. Preliminary data
demonstrate multiple similarities between EqPV-H in horses and parvovirus B19 in humans, including high
prevalence in clinically healthy individuals and rare but important associations with fulminant hepatitis.
Parvoviruses utilize either the host cell replication machinery or the DNA damage response (DDR) pathway to
replicate their viral genomes. The foundation for this proposal is based on studies evaluating the cellular division
status of hepatocytes infected with EqPV-H following experimental inoculation in vivo that suggest that cells with
viral replication are most commonly in G0 phase of the cell cycle.
This proposal will address the following specific aims: Aim 1) Determine the cellular division and DNA
damage response (DDR) status of EqPV-H-infected hepatocytes and association with pathology in situ; Aim 2)
Evaluate the impact of DNA damage-induced DDR activation and DDR inhibition on EqPV-H replication and
hepatotoxicity in vitro; and Aim 3) Determine the role of host cell polymerases in EqPV-H replication in vitro.
These aims align with Dr. Jager’s career development goals: 1) Training in cell culture development and
optimization; 2) Training in molecular virology, cell biology, and toxicology; and 3) Training in confocal
microscopy and spatial transcriptomics. To achieve these goals, Dr. Jager has assembled a highly qualified team
of mentors including: his primary mentor, Dr. Gerlinde Van de Walle, a veterinary clinician-basic scientist with
expertise in viral pathogenesis and development of novel cell culture systems; co-mentor Dr. Colin Parrish, a
skilled molecular virologist with extensive parvovirus research experience; and co-mentor Dr. Robert Weiss with
expertise in the DDR pathway. Additionally, the team includes collaborators with expertise in parvoviral
replication dynamics, hepatopathology, and equine parvovirus.
The candidate plans to submit grants for further federal funding, including an R21 or R01 in the fourth
year, with the goal of achieving independence. This K08 award will allow Dr. Jager to develop a sub-specialty in
hepatopathology and viral pathogenesis that will help launch his academic career as an independent clinician-
scientist.

Public health relevance
Project Narrative: The study of animal viruses has been critical for understanding basic disease mechanisms, including the origin and pathogenesis of related human viruses. In this career development proposal, Dr. Jager will use a novel hepatotropic equine parvovirus to study the role of the DNA damage response pathways in viral genome replication and the impact of exogenous DNA damage on viral hepatitis. These findings will have broad implications on the fundamental mechanisms of viral DNA replication and the synergy between toxins and hepatotropic viruses in humans and animals.